Evaluating a novel approach-avoidance model of repetitive behaviors in autistic adolescents: A multi-method study

ABSTRACT
Repetitive behaviors comprise one of the two core domains of symptoms for an autism spectrum disorder
diagnosis (hereafter ‘autism’), and the lived experience of autistic individuals suggests that these behaviors serve
important functions that are largely misunderstood and poorly addressed clinically. Autistic individuals report
engaging in repetitive behaviors for reasons related to enjoyment and reasons related to distress (i.e., to
decrease stress and anxiety). The field lacks a validated model that encompasses these seemingly polarized
lived experiences, which negatively impacts our ability to provide appropriate supports, and educate the public
to better accommodate autistic individuals. The guiding scientific premise of this R21 is that autistic individuals
are driven to engage in repetitive behaviors via both approach (enjoyment) and avoidance (avoiding/easing
exposure to negative stimuli) mechanisms. The approach component of the model is supported by a burgeoning
literature and our preliminary work demonstrating that measures from the Research Domain Criteria’s Positive
Valence System are implicated for special interest repetitive behaviors. The avoidance component of the model
is supported by a robust literature and our preliminary data associating sensory reactivity and insistence on
sameness repetitive behaviors with measures from the Research Domain Criteria’s Negative Valence System.
The objective of this project is to take the first step in evaluating the approach-avoidance model of repetitive
behaviors in a study with autistic adolescents. Adolescence is a developmental period when many autistic youth
can reflect on the drivers of their repetitive behaviors. Aim 1 will recruit 250 autistic adolescents between the
ages of 13 and 17 and a caregiver to provide ratings on the type of repetitive behaviors they engage in, approach
and/or avoidance motivations for engaging in the behavior(s), and the intensity of the emotional valence
associated with each repetitive behavior. We will derive latent profiles of repetitive behaviors as a novel method
for parsing the heterogeneous clinical presentations of repetitive behaviors. Aim 2 will recruit 60 teens from Aim
1 to complete neuroimaging and behavioral protocols associated with the Research Domain Criteria’s Positive
Valence (approach), and Negative Valence systems (avoidance); the goal is to link these dimensional
assessments of approach and avoidance mechanisms with self-report of valence direction and intensity of
repetitive behaviors. We hypothesize that Aim 1 will yield 3 unique latent profiles—Predominantly Approach,
Predominantly Avoidant, and Mixed Approach/Avoidant—and that Aim 2’s canonical correlation analyses will
show the Positive Valence System to be associated with approach repetitive behaviors and Negative Valence
System to be associated with avoidance repetitive behaviors. This line of research has the potential to redefine
models of repetitive behavior to align with the autistic lived experience, and to enhance clinical supports through
identifying novel target mechanisms that are malleable or through education to the general public to better
accommodate the needs of autistic people.

Public health relevance
PROJECT NARRATIVE Repetitive behaviors are core symptoms of an autism spectrum disorder diagnosis—excessive engagement in repetitive behaviors has been associated with a lower quality of life and repetitive behaviors have been identified as adaptive supports for managing negative emotional experiences—and yet no single neurocognitive model of repetitive behaviors accounts for these variable approach and avoidance motivations. This study evaluates a novel approach-avoidance model of repetitive behaviors by leveraging first-hand reports of motivation and valence ratings from autistic adolescents to identify underlying profiles from this diverse set of core autism symptoms, and by associating these valence intensity ratings with the approach and avoidance domains from the Research Domain Criteria Matrix, the Positive and Negative Valence Systems, respectively. The rich foundational knowledge generated from this project will take the first step in validating a neurocognitive model that aligns with the lived experience of autistic adolescents and identify pathways to adapting or developing supports for repetitive behaviors, ultimately improving the lives of autistic individuals.